NASAL CANNULA/PRESSURE TRANSDUCER RESPIRATION IN THE ICU

The specific aims of this protocol are to classify respiratory events (apnea and hypopnea) and periodic breathing in critically ill patients as either central or obstructive using a nasal cannula/pressure transducer system allowing recognition of flow limitation; to compare this classification to the reference standard measure of respiratory effort by esophageal manometry; to characterize the respiratory events detected in the ICU/post-operative patients who are not suspected of having a primary sleep disorder; and to correlate the inpatient sleep patterns with a full night sleep study.